MR-compatible Devices for the Diagnosis and Treatment of Cardiomyopathies

Cardiac magnetic resonance (CMR) is a non-invasive imaging technique with exquisite soft-tissue detail for the
assessment of heart structure and function and provides an excellent screening tool but cannot always obviate
more invasive procedures, such as endomyocardial biopsy (EMB). Interventional CMR (iCMR) is a minimally
invasive technique without radiation, which has been hampered by the lack of non-ferrous devices that can be
easily visualized, enabling the navigation of tasks, such as EMB, safely. Currently, one in nine deaths in the
US is attributed to heart failure (HF), with health care costs exceeding $30 billion in 2013. Of the ~5.1 million
Americans with HF, the definitive treatment is heart transplantation (HTx), where rejection is assessed with
endomyocardial biopsy (EMB) – a procedure performed under X-ray guidance to obtain random samples of the
right ventricular septum. However, many patients, especially children with cardiomyopathy and after HTx and
HF caused by non-ischemic cardiomyopathies (NICM), do not have global changes to the myocardium, but
rather, patchy disease, which is often restricted to limited portions of the left ventricle. Thus, EMB may yield a
definitive diagnosis in <20% of the cases. As complications of EMB include ventricular puncture, pericardial
tamponade, stroke, and death, the risk-benefit ratio of EMB limits its use. However, accurate diagnosis of
cardiomyopathies or early recognition of heart rejection can lead to definitive treatment or measures to avoid
heart rejection, respectively, with enormous individual patient impact. Therefore, we propose to develop an
MRI-compatible suite of interventional devices to allow direct targeting of diseased myocardium (based on
CMR) for EMB and treatment of cardiomyopathies, for both right- and left-sided catheterization. To this end,
we will develop an active pigtail catheter with a guidewire for iCMR cardiac catheterization to be used in
combination with an active MR-steerable sheath/bioptome device or transmyocardial injection catheter. These
devices will enable direct targeting of the disease to increase diagnostic yield and decrease complications.
Currently, there are no commercially available active MR-visible EMB, pigtail, or injection catheters. Significant
advances to our realization of a clinically relevant MR-EMB device include the creation of a sharp-jaw EMB
mechanism that is safe from heating, but provides a specific MR signature when the device is open vs. closed,
and injection devices that can determine myocardial apposition so that therapeutics reach the intended target
of the myocardium. Furthermore, as pediatric HTx patients receive up to six EMBs in the first year, the iCMR
suite of devices will significantly reduce ionizing radiation in a particularly vulnerable population. Our research
proposal will develop these devices in a canine model of spontaneous NICM that is similar in size to children's
hearts to ensure these are compatible with pediatric interventions. Our extensive expertise in MRI
interventional devices and CMR will be used to achieve this objective. Thus, our goal will be to develop these
MR-guided devices to expand the reach of iCMR to children and adults.

Public health relevance
Project Narrative: This proposal seeks to create magnetic resonance imaging (MRI)-visible devices for minimally invasive interventional procedures that will help diagnose diseases in the heart wall called cardiomyopathies and treat heart disease to decrease the likelihood of developing heart failure. Extensive testing of an MRI-compatible endomyocardial biopsy device, an MRI-compatible injection catheter, and MRI-compatible pigtail catheter will be performed on the benchtop and in dogs as a model for both pediatric and adult patients. In addition, we will test these devices using a new paradigm for device development in cardiovascular disease by studying spontaneously occurring non-ischemic cardiomyopathies in client-owned dogs, such as Irish Wolfhounds, to provide a more realistic model for translation to human clinical trials using the same whole body MRIs that are also used for patient studies.